Sleep and circadian timing and suicidal thoughts and behavior in youth: The role of self-referential processing and its neural correlates

Suicide is the second leading cause of death among 15-24-year-olds. To address this significant public
health concern, this study seeks to advance our understanding of the daily interplay of sleep and the
biological clock and how teens think of themselves with their thoughts of suicide. This proposal's central
hypothesis is that a prolonged time interval between feeling sleepy and actual bedtime creates unique
opportunities to engage in nighttime self-critical rumination-repetitive negative thinking about self and
diminishes teens' ability to self-reassure (supportive of self). We also investigate how neural processing of
self-criticism and self-reassurance varies based on the circadian timing, potentially affecting their
subsequent sleep and next-day suicidal thoughts. Our central methodology is to examine the interface of
sleep and biological clock and nighttime self-critical rumination and self-reassurance with next-day
suicidal thoughts using ecological momentary assessment (EMA}, gold-standard assessments of
circadian timing and sleep, and functional magnetic resonance imaging (fMRI) in 60, 13-17-year-old
youth. Teens will be recruited on a range of suicidal thoughts from the inpatient, partial hospitalization,
and outpatient care, as well as the community. This age group represents a critical developmental period
for self-referential processes and sleep changes, and youth in this age group experienced a sharp
increase in suicide rates over the last decade. This proposal innovatively links nighttime self-critical
rumination and self-reassurance with next-day subsequent suicidal thinking via circadian rhythms and
sleep by integrating (i) state-of-the-art biological clock and sleep measures for objectivity; (ii) EMA
techniques for real-life meaning; and (iii) fMRI techniques to identify neural treatment targets. This
research is significant because characterizing brain-behavior mechanisms of the association of circadian
timing and sleep behavior with nighttime self-critical rumination, self-reassurance, and next-day suicidal
thinking can contribute to developing novel mobile interventions that target self-referential thinking and
sleep to reduce suicide risk in youth.